Small molecule allosteric inhibitors of PCSK9 processing to phenocopy cardioprotective genetic variants.

PROJECT SUMMARY/ABSTRACT
The self-cleaving protease PCSK9 induces the lysosomal degradation of the hepatic low-density lipoprotein
receptor (LDLR). Thus, PCSK9 raises serum LDL and promotes atherosclerotic heart disease. Human
genetics show that secreted PCSK9 is dispensable, making PCSK9 an important drug target. Both therapeutic
anti-PCSK9 antibodies and liver-specific anti-PCSK9 siRNA impressively lower LDL and improve
cardiovascular outcomes, even when added on top of statins. Yet despite this clinical success, problems
remain. First, the role of PCSK9 beyond downregulating the hepatic LDLR remains unclear, and so there are
gaps in the knowledge of the site effects from or other indications for the current available therapies. Second,
currently approved therapies are not orally available, expensive, and poorly covered by insurance (antibodies),
or phenocopy genetic models that associate with liver disease (siRNA).
In this proposal, we target a novel mechanism for PCSK9 inhibition: the disruption of PCSK9 processing.
PCSK9 is a self-cleaving protease, and this auto-proteolysis is required for its secretion and full effect on the
LDLR. However, because PCSK9’s cleavage is both intramolecular and terminal, no other group has
discovered how to disrupt it. Our group, however, has solved this problem, and we have discovered a series of
molecules that allosterically modulate PCSK9 proteolysis to disrupt PCSK9 function. Importantly, this
mechanism phenocopies the well-tolerated human PCSK9 variants who have no adverse phenotypes, only
lower LDL and cardiovascular protection. In the R61 phase of this proposal, we will pursue a medicinal
chemistry campaign to identify, validate, and screen compounds for activity. We will generate a diversity library
to establish novel intellectual property, confirm target engagement with PCSK9, and improve the efficacy,
potency, and pharmacologic properties of our compounds. In the R33 phase, we will establish in vivo efficacy
and pharmacologically validate a developmental candidate to identify a lead compound for IND-enabling
studies. We anticipate that our proposal will have a high impact on cardiovascular disease by enabling the
development of an oral small molecule inhibitor of PCSK9 that truly phenocopies the cardioprotective genetic
variants found in humans.

Public health relevance
PROJECT NARRATIVE PCSK9 is a known drug target for lowering LDL cholesterol and treating atherosclerotic heart disease, but there are currently no approved orally available therapies. This proposal aims to develop orally available small molecule therapeutics that inhibit PCSK9 by a unique mechanism, stopping the processing of PCSK9 to its mature form. This mechanism mimics the well-tolerated human genetic variants that lower LDL cholesterol and protect against heart disease.